Computerized tests of cognitive decline in presymptomatic Alzheimer’s disease

Abstract. Hispanic Americans are the largest and fastest growing US minority and, over coming
decades, will show the largest relative increase in Alzheimer’s disease (AD) incidence of any
ethnic group. However, Spanish-speaking Hispanics have been largely excluded from clinical
trials and research studies for several reasons: (1) Only 5.5% of US neuropsychologists have
sufficient fluency to administer cognitive tests in Spanish; (2) Existing Spanish-language
cognitive tests lack adequate norms for older Hispanic Americans, and (3) many Hispanics live
in rural or hard-to-reach locations that make test administration challenging. Here, we propose
to create a Spanish version of the California Cognitive Assessment Battery (CCAB) and gather
normative data from 256 older Spanish-speaking Hispanics, telemedically tested in their homes.
CCAB-Spanish will significantly enhance access to cognitive testing for US Hispanics for
several reasons: (1) Automated and computerized test delivery and scoring means examiners
with limited Spanish fluency can administer CCAB-Spanish tests, with on-call interpreters as
needed; (2) Nationwide telemedical administration reaches populations underserved by manual
testing; and (3) A single examiner can remotely test multiple subjects concurrently making
clinical assessments of cognition economically feasible in economically disadvantaged
populations. The supplement will further enhance the long-term scientific and commercial
impact of the CCAB, and provide older Spanish-speaking US residents with improved access to
cognitive testing.

Public health relevance
Project Narrative Alzheimer’s disease is a health care burden with enormous medical and personal cost that will affect an increasing number of Americans as the population ages. Cognitive testing plays a central role in identifying at-risk patients: declines in scores on tests of memory and other mental functions can be detected long before the onset of dementia. Moreover, the success of clinical trials for new therapies designed to reverse Alzheimer’s pathology and/or slow cognitive decline depends on the sensitivity of the tests used to detect cognitive deterioration. The cognitive tests currently used are mostly “paper-and-pencil” assessments that require manual administration. We propose to develop a set of innovative, computerized cognitive tests with greater sensitivity and reliability than manual tests, and demonstrate their increased sensitivity to cognitive decline by repeatedly testing a large group of older individuals, including some with increased genetic risk for Alzheimer’s disease.